Intratumor heterogeneity in BRCA1-mutated breast cancer metastasis

Abstract
Metastasis continues to cause the vast majority of breast cancer related deaths because the metastatic
process is poorly understood and therapies for effectively inhibiting it do not exist. Women with BRCA1
mutations develop the most aggressive, and highly metastatic basal-like breast cancer at a high rate. Despite
resembling basal epithelial cells, recent studies have identified the luminal progenitor as the cell type which
undergoes malignant transformation in basal-like breast cancer. Preliminary sequencing data included in this
proposal, from same-cell gene expression and chromatin accessibility epigenetics assay in a mouse model of
basal-like breast cancer, reveal the presence of several differentiation states of luminal progenitor cells within
the tumor. Additionally, several tumor cell states appear to have unique DNA copy-number mutational
signatures. These observations prompt the questions of whether a particular differentiation state is involved in
metastasis and if mutations drive the differentiation and metastasis trajectory.
To investigate the metastatic potentials of the cellular differentiation states and mutational cell subpopulations
in the tumors, the proposed study will consist of the following methodological steps: 1) harvesting
spontaneously generated Brca1&p53-mutant mouse tumors, 2) injection of tumor cells into mice to generate
metastasis replicates, 3) isolation of metastatic cells using mouse strain-specific antibodies, 4) splitting of
metastatic cells and original mammary tumor cells for parallel single cell profiling with a) gene expression and
chromatin accessibility assay and b) custom-built high-resolution mutation panel, 5) data integration to
incorporate the contribution of mutations, epigenetic chromatin states, and gene expression, 6) computational
comparison of metastatic cells to original tumor cells. This study is expected to reveal the molecular markers
which define metastatic cells in Brca1&p53-mutant tumors to inspire metastasis inhibiting therapy.
This study will be carried out by a student with substantial training in molecular pathology and systems biology
who wishes to further her cancer genomics and bioinformatics training. Laboratory animal personnel will assist
with animal work, the bioinformatics director will guide the computational analysis and statistical tests, and the
faculty advisor/sponsor will oversee experiments and interpretations of results. The student will work closely
with the sponsor and the bioinformatics collaborator to learn the proper use of cutting edge genomics and
bioinformatics tools to advance the breast cancer metastasis field. Additionally, the student will be given
professional development opportunities such as attending conferences, mentoring undergraduates, and
teaching a summer course to prepare her for a post-doctoral position in a cancer-related field.

Public health relevance
Narrative The vast majority of breast cancer related deaths are caused by the metastatic spread of cancer from the breast to other organs in the body. This project would help to understand which types of cells from the tumor are capable of colonizing the major organs in the body. In the long term, this information should point to ways of preventing metastasis and more effective ways to treat patients who already have metastatic breast cancer.